Administrative Core

PROJECT SUMMARY
The overall goals of the University of Florida (UF) Resource Center for Minority Aging Research (RCMAR) are
to 1) to promote the diversity of the aging research workforce by identifying, supporting, and mentoring promising
investigators from underrepresented backgrounds; and 2) to enhance the health of older populations by
conducting state-of-the-art interdisciplinary research investigating social and behavioral contributions to pain and
disability in later life. The UF RCMAR Administrative Core (AC) will provide intellectual leadership and
programmatic oversight to the Center. Directed by two highly accomplished scientists with extensive leadership
experience, the AC will be responsible for implementing all aspects of the RCMAR program and for coordinating
all RCMAR activities in support of its mission. A key function of the AC will be to promote cohesion and synergy
across the RCMAR Cores. The AC will ensure that the UF RCMAR maintains its scientific focus on pain and
disability among older adults. Further, the AC will facilitate the success of the UF RCMAR by promoting
interactions and collaborations between other entities at UF and with programs at other institutions. The AC will
accomplish its goals through the following activities. First, the AC will stimulate interactions among RCMAR
Cores and RCMAR Scientists, as well as with other components and investigators within and outside of UF. In
this regard, the AC will spearhead joint initiatives between the UF RCMAR and key partners, including the Pepper
Older Adults Independence Center (OAIC), the Clinical and Translational Science Institute (CTSI), and the Pain
Research & Intervention Center of Excellence (PRICE). Second, the AC will work closely with the Research
Education Component (REC) to recruit and retain outstanding investigators from underrepresented backgrounds
conducting research addressing the UF RCMAR’s global theme of pain and disability in older adults. The AC will
also engage the Community Liaison and Recruitment Core (CLRC), including its HealthStreet Program, to
provide support for RCMAR Scientists and to promote community engagement, to ensure that RCMAR-
supported research has high community relevance. Finally, the AC will develop strategies for monitoring and
evaluating the success and accomplishments of the UF RCMAR, including the RCMAR Cores as well as RCMAR
Scientists. In order to optimize its functioning, the AC will solicit input from multiple sources, including External
and Internal Advisory Committees, an Executive Committee, and from the community via the Citizen Scientist
Panel. The AC will prepare annual reports for the NIA and will ensure productive collaborative relationships with
other RCMARs, including the Coordinating Center.